Dynamic RNA-Protein Assemblies and Neurological Disease

PROJECT SUMMARY
Biomolecular condensates such as ribonucleoprotein (RNP) granules play a pivotal role in governing various
aspects of RNA metabolism. Diverse genetic mutations converge on the process of biomolecular
condensation, causing a spectrum of neurodegenerative diseases that includes amyotrophic lateral sclerosis,
frontotemporal dementia, and inclusion body myopathy. Over the past decade, our lab has been at the
forefront of illuminating the molecular basis for these diseases, including identifying novel disease genes,
elucidating the normal function of these and other disease-related genes, and determining the biophysical,
molecular, and cellular consequences of disease-causing mutations. These investigations have generated
comprehensive insights into the regulatory mechanisms orchestrating condensation, particularly within stress
granules, a type of RNP granule. Moreover, our studies have elucidated higher-order regulatory mechanisms
governing condensation beyond stress granules. However, challenging questions remain regarding the
physiological functions of biomolecular condensates, how condensates establish distinct identities despite
sharing common constituents and principles of assembly, and how the dysfunction of biomolecular
condensates is related to the pathogenesis of neurological disease.
We have developed a comprehensive research program that, over the next 8 years, will address these
remaining challenging questions. These include rigorous testing of the network-encoded percolation threshold
hypothesis, which has the promise of providing a blueprint for understanding how cells regulate condensation
as well as how we may be able to exogenously manipulate condensation for experimental or therapeutic
purposes. Our research program also encompasses the investigation of regulatory factors governing the
process of biomolecular condensation and decondensation. Finally, we aim to delineate the mechanisms
whereby condensate dysfunction contributes to neurological diseases. Collectively, our research program will
provide a comprehensive understanding of the dynamics of biomolecular condensation and the relevance of
these assemblies to health and disease.

Public health relevance
PROJECT NARRATIVE Biomolecular condensation is a process by which cells organize their contents and compartmentalize their functions. Dysfunction in biomolecular condensation is central to common neurodegenerative diseases, such as amyotrophic lateral sclerosis (ALS). Our research program will focus on understanding the regulatory mechanisms of biomolecular condensation and will investigate how condensate dysfunction contributes to neurological diseases, ultimately enhancing our understanding of condensation dynamics and function in health and disease.